2024 Epithelial Mesenchymal Transition (EMT) International Meeting

Abstract
The specific aim of this proposal is to obtain partial funding for the expenses (travel and lodging) for junior
investigators, postdoctoral fellows and graduate students from the USA to attend the 11th International Meeting
on Epithelial-Mesenchymal Transition. The meeting will be held November 12-15, 2024 at The Allen Institute for
Cell Science in Seattle, WA, USA under the auspices of The Allen Institute for Cell Science and the Epithelial-
Mesenchymal Transition International Association (TEMTIA).
The objectives of the meeting are to 1. Bring together investigators in the separate disciplines of cancer,
pathology and development to discuss their observations on EMT and explore whether there is a consensus on
important components of the process. 2. Provide a forum where students and junior investigators can interact
with senior investigators and display their own work and ideas in the field. 3. Expand a viable co-operative cross
disciplinary forum of EMT-related researchers internationally. This will continue to provide a worldwide network
for exchange of expertise, reagents and techniques across disciplines. 4. Publish a timely meeting update on
cellular, molecular and genetic aspects of EMT in an appropriate cross-disciplinary international journal.
Epithelial-mesenchymal transition (EMT) is a fundamental cellular process undertaken by cells in the embryo to
form 3-dimensional structures from sheets of cells. During EMT, epithelial cells lose adherence to adjacent cells,
degrade the local basement membrane and invade the underlying interstitial extracellular matrix. At the cellular
level, this process requires specific signal transduction elements, new gene transcription, reorganization of the
cytoskeleton, secretion of extracellular matrix molecules and growth factors. In the embryo, this process is
reiterated at gastrulation, neural crest cell formation, somite breakdown, pancreatic islet formation, heart valve
formation brain organization and in several other areas of organogenesis. In the adult, EMT occurs as a
component of wound healing and in the pathologies of cancer metastasis and tissue fibrosis.

Public health relevance
Project Narrative Support is requested for travel by academic US scientists to participate in a scientific meeting that brings together researchers exploring common aspects of cell invasion in development, cancer, and organ fibrosis. The field of Epithelial Mesenchymal Transition is rapidly expanding and the conference will bring together groups of developmental biologists, cell biologists, and cancer biologists who do not normally intersect to address cutting- edge research on EMT.